Longitudinal changes in the Gut Microbiota in Non-infectious Uveitis

ABSTRACT
To date, the immunological mechanisms that underpin non-infectious uveitis (NIU) are not fully understood. The
contribution of the gut microbiota and their metabolites to the development of autoimmune diseases is
increasingly being recognized. Recent evidence suggests that alterations in the gut microbiota in certain
systemic autoimmune diseases are associated with disease flares, and that restoration of altered microbiome
composition occurs following treatment of the disease. Like systemic autoimmune diseases, the gut-eye axis
has been implicated as an important factor in intraocular inflammation. However, comparatively less is known
about the gut microbiota in the development of uveitis, and to date, longitudinal studies are lacking. We
hypothesize that distinct alterations in the gut microbiota and metabolome will be observed with changes in
disease activity in NIU. Thus, the overall goals of this study are to compare the gut microbiota and metabolome
in patients with active posterior segment NIU with healthy controls (HC) and investigate the longitudinal changes
in the gut microbiota composition and metabolome in patients with NIU to detect associations with disease
activity and determine whether these alterations resolve following treatment. Specifically, the scientific aims of
this proposal are the following: 1) Investigate how longitudinal differences in gut microbiota composition and
diversity in NIU change with disease activity; 2) investigate longitudinal alternations in the fecal metabolome in
NIU; and 3) utilize a machine-learning approach with predictive modelling to identify NIU patients responsive to
treatment and those at risk of treatment failure. The successful completion of the proposed aims will lead to an
improved understanding of the relationship between the gut microbiota and fecal metabolome in NIU and disease
activity and inform precision medicine approaches to NIU. My overarching goal is to become an independent
physician-scientist leading a translational research program focused on ocular inflammatory diseases. To
facilitate my transition towards independence, I have together with my mentors developed a structured training
plan which complement my scientific objectives. I will receive training through a combination of hands-on
learning and didactics on the following objectives: 1) developing expertise in gut microbiome studies including
study design and bioinformatics skills in the analysis of 16S rRNA and fecal metabolome data; 2) acquiring
training in advanced biostatistics, integration of large data sets, and predictive modelling; and 3) cultivating the
skills required to effectively direct an independent laboratory. I will benefit from the outstanding environment at
the University of Michigan for early career physician-scientists and leverage the deep institutional expertise in
microbiome and metabolomics studies to complete the proposed work.

Public health relevance
PROJECT NARRATIVE Uveitis refers to a sight-threatening and heterogeneous group of ocular inflammatory diseases that have been estimated to account for up to 15% of all cases of blindness in the United States. The overall goal of this study is to investigate how the gut microbiota and metabolome change with disease activity in non-infectious uveitis. An improved understanding of these changes will inform precision medicine approaches in uveitis and potentially facilitate modulation of the gut microbiota as a therapeutic strategy.